CALM-PD PARALLEL GROUP DP, STUDY OF PRAMIPEXOLE AND CARBIDOPA-L IN PD

The primary goal of this study is to compare the initial treatment with pramipexole and initial treatment with carbidopa-levbodopa in early, symptomatic PD with regard to the development of dopaminergic motor complications. Dopaminergic motor complications are defined as: "wearing-off", "on-off effects", and "dyskinesias".